Molecular Mechanism of the NFkappaB Essential Modulator (NEMO) Scaffold Protein Mutated in Human Immunodeficiencies

PROJECT SUMMARY/ABSTRACT Signal transduction pathways play pervasive and important roles in normal cellular physiology, and alterations in these pathways are found in many human diseases. One under-studied aspect of many signal transduction pathways is the role of scaffold proteins, which act as integrating platforms for signaling proteins. The NF-κB signaling pathway is altered in many inflammatory and immune diseases and cancers, and is thus viewed as target for therapeutic intervention. The overall project goal is to advance our understanding of the signaling scaffold protein NF-κB essential modulator (NEMO), a component of the inhibitor of κB kinase (IKK) complex, which is a key regulatory node for NF-κB signaling. In addition to NEMO playing a role in the chronic hyperactivity of NF-κB in human diseases, mutations in NEMO are found in several human immunodeficiency diseases. The long-term goals of the project are to understand how scaffolding proteins such as NEMO use conformational change to regulate the functional interactions between the signaling proteins that are bound to them, to elucidate the structural basis for disease-causing mutations in key regions of NEMO, and to identify new target sites for small molecule drugs that modulate NEMO activity. The following specific aims will be pursued: 1. Structural, biophysical and molecular approaches will be used to characterize the newly discovered “Intervening Domain” (IVD; aa 111-195) of NEMO, and to elucidate the role that the IVD plays in modulating IKKβ binding. Additionally, the mechanism(s) underlying immunodeficiency disease-causing mutations in the IVD region will be established. 2. The recently discovered interaction between NEMO and IκB? will be characterized using biochemical and cellular approaches, to establish whether this interface provides alternative target sites for therapeutic intervention. 3. The mechanism by which NEMO regulates the phosphorylation of IκB by IKKβ, and the role in this process played by a conformational change in NEMO, will be assessed and defined. The project team includes three Principal Investigators with expertise and experience across all aspects of the project, including assay development, quantitative and mechanistic biochemistry, X-ray crystallography and small-angle X-ray scattering (SAXS), biophysics, drug discovery, and NF-κB pathway biology and disease. The outcomes of this research will further our understanding of the role of NEMO in normal cellular physiology and in NEMO-related genetic immunodeficiencies, and may lead to the development of new therapeutics for human disease.

Public health relevance
PROJECT NARRATIVE The goal of this project is to advance our understanding of how the NF-κB Essential Modulator (NEMO) scaffold protein functions to mediate NF-κB pathway signaling by directing phosphorylation of Inhibitor of kappa-B (IκB) by IκB Kinase subunit β (IKKβ). Our work will establish the mechanism of action of disease- causing mutations that occur in a previously uncharacterized region of NEMO, and will elucidate the role of conformational change and allostery in NEMO function. The results of this research will have implications for how other scaffolding proteins function, and may lead to the development of therapeutic approaches to human diseases involving NEMO or other scaffolding proteins.